Determinants of susceptibility to pediatric acute myeloid leukemia

F99CA294248
PI: Lauren Harmon
Administrative Supplement for Fellowship Award – Childcare Costs
PROJECT SUMMARY/ABSTRACT
No change from original submission.

Public health relevance
F99CA294248 PI: Lauren Harmon Administrative Supplement for Fellowship Award – Childcare Costs PROJECT NARRATIVE No change from original submission.